LATE OUTCOMES OF TREATMENT FOR HIV INFECTION

This is a study of long-term outcomes for children who were ever treated on ACTG studies, to follow for unexpected late side effects of drug therapies and unexpected effects of treatment or the disease process.